Integrative Model of Metabolomics, Equol and Atherosclerotic cardiovascular disease (IMMEA)

PROJECT SUMMARY
This proposal, IMMEA (Integrative Models of Metabolites, Equol and Atherosclerotic cardiovascular disease),
aims to (1) determine the association of equol-producing status with ASCVD (atherosclerotic cardiovascular
disease) and (2) build models of ASCVD from equol, marine omega-3 fatty acids (OM3), metabolites, and
other factors using Probabilistic Graphical Models (PGMs). To achieve these goals, we will leverage the
unique datasets from two case-control studies of ASCVD nested within the Tsuruoka Metabolomics Cohort
Study (TMCS) and the Tohoku Medical Megabank Project (TMMP) in Japan. ASCVD mortality in Japan is less
than half of that in the US despite a worse profile of lifetime exposure to many traditional risk factors in Japan.
It has decreased continuously for the past five decades despite a noticeable rise in total cholesterol. Studies of
migrant Japanese to the US showed a dramatic increase in ASCVD rates, indicating that the low ASCVD
mortality is not due to genetic susceptibility but environmental exposure specific to Japan. Diet is a major
environmental determinant of ASCVD. The Japanese diet stands out due to its high soy isoflavones (SIFs) and
OM3 consumption. While studies in Japan show that SIFs are cardioprotective, a randomized clinical trial
(RCT) of SIFs in the US failed to show their benefit. We posit that this discrepancy is due to equol producing
capability. Equol, a metabolite of SIFs, exhibits the most potent anti-atherosclerotic properties among all SIFs.
In Japan, 40-70% of individuals produce equol after SIF consumption, while RCTs of SIFs in the US reported
equol production rates of 20-30%. No previous study has examined the association of equol with ASCVD in
Japan. We and others show a significant inverse association of dietary intake of OM3 with ASCVD rates in
Japan. Underlying mechanisms linking high dietary intake of OM3 and ASCVD are not fully understood.
Metabolomics has emerged as a tool to decipher biological mechanisms. Metabolomics studies of ASCVD
typically rely on statistically independent tests, neglecting higher-order dependencies among variables. PGMs
provide a flexible framework for modeling extensive collections of variables with complex interactions, yet
PGMs have not been applied to integrative metabolomics analyses in ASCVD. To bridge these critical gaps,
IMMEA will conduct two case-control studies of 1,200 subjects nested within each TMCS and TMMP.
Completing this study has the potential to provide profound insight into the biological mechanisms underlying
the benefits of the Japanese diet, with implications for the prevention of ASCVD in the US.

Public health relevance
PROJECT NARRATIVE Atherosclerotic cardiovascular disease (ASCVD) is the leading cause of death in the US. Despite a worse profile of lifetime exposure to many ASCVD risk factors in Japan, ASCVD mortality is less than half of that in the US. Understanding the mechanisms of low ASCVD mortality in Japan could lead to novel preventive and therapeutic strategies for reducing the burden of ASCVD in the US.